Leveraging HSF1 Attenuation to Transform Clonal Hematopoiesis into Beneficial Hematopoiesis

Project Summary_Abstract
Age-related clonal hematopoiesis (CH), characterized by the enhanced fitness of hematopoietic
stem/progenitor cells (HSPCs) carrying somatic mutations, is associated with increased risks of developing
hematological malignancies such as myelodysplastic syndrome or acute myeloid leukemia (AML), as well as
solid tumors, cardiovascular disease, chronic obstructive pulmonary disease, and severe symptoms during
certain microbial infections. While CH is often linked to unfavorable outcomes, it also corelates with beneficial
conditions, including a reduced risk of Alzheimer disease, an increase in the graft-versus-leukemia effect, and
preserved T-cell immunity. The central question arises: Can we sustain the heightened self-renewal of HSPCs
associated with CH while preventing its progression? Heat shock transcription factor 1 (HSF1) plays a pivotal
role in cellular stress responses, metabolism, aging, and cancer. Our recent research, involving genetic
knockout and pharmacological degradation of HSF1, has highlighted its critical role in maintaining AML stem
cells while being nonessential in normal HSPCs. Utilizing newly generated DNMT3a/HSF1 and TET2/HSF1
double knockout mouse models, we observed that the deletion of HSF1 along with Tet2 or Dnmt3a sustains or
enhances HSPC engraftment and maintains balanced lineage commitment. Notably, these double knockout
mice exhibit a reduced incidence of myeloid or lymphoid neoplasms compared to counterparts with sole TET2
or DNMT3a deleted. Gene set enrichment analysis revealed an upregulation in mitochondrial oxidative
phosphorylation (OXPHOS) and/or glycolysis pathways in DNMT3aHSF1 or TET2/HSF1 doubly deleted
HSPCs compared to those with sole DNMT3a or TET2 deletions. Additionally, we found that HSF1 protein
expression is higher in bone marrow immature cells compared to mature cells, upregulated in TET2 and
DNMT3a deleted bone marrow cells, and decreased during aging, suggesting a potential protective role in
maintaining HSPC function in CH. The observed ability of HSF1 deletion to sustain or enhance HSPC self-
renewal, maintain balanced lineage commitment, and prevent CH progression underscores its appeal as a
target. Based on these preliminary findings, we hypothesize that modulating HSF1 may hold the key to
transforming detrimental CH into a state favoring normal hematopoiesis while simultaneously
preventing CH progression. We aim to address the following two fundamental questions: 1) how
DNMT3aHSF1 or TET2HSF1 doubly deleted HSPC function is maintained or enhanced with upregulated
mitochondrial function, considering the consensus that adult HSPC homeostasis relies on glycolysis; and 2)
how HSF1 deletion prevents CH progression and the impact of HSF1 nuclear degrader in CH. These findings
have the potential to significantly impact the development of targeted interventions, preserving normal
hematopoiesis and impeding CH progression.

Public health relevance
Project Narrative The proposed research aims to redefine the understanding of clonal hematopoiesis by exploring how the attenuation of HSF1 might potentially redirect detrimental clonal hematopoiesis towards favoring normal hematopoiesis while inhibiting its progression. These findings hold the potential to significantly impact the development of targeted interventions, ensuring the preservation of normal hematopoiesis and impeding the progression of clonal hematopoiesis.